Surveillance of Animal Food Products for Microbial and Chemical Contaminants by LDAF Agricultural Chemistry Laboratory to Support FDA's National Integrated Food Safety System.

OVERALL ABSTRACT
The Louisiana Department of Agriculture and Forestry (LDAF) Agricultural Chemistry
Laboratory is proposing to test microbiological and chemical constituents in animal food for the
integrated food safety system established by the FDA. All samples, 100 for microbial analysis and
250 for chemical analysis, will be collected statewide under the directive of LDAF Feed Program
which is Animal Feed Regulatory Program Standards (AFRPS) compliant. Proximity to the feed
program will allow immediate regulatory action ensuring the health of both humans and animals.
Additionally, the Agricultural Chemistry Laboratory is accredited to ISO 17025:2017, with
validated methods on scope for analyzing Salmonella spp., aflatoxin, fumonisin, DON, minerals
and metals in animal feeds and pet foods. It houses all pertinent analytical equipment as well as
experienced and competent personnel needed to maintain quality data for this nationally
integrated laboratory food safety system. The organizational position held by the LDAF
Agricultural Chemistry Laboratory places it in a strategic position to produce sample outputs that
will add to a risk-based and prevention focused food safety system that both the Food and Drug
Administration (FDA) as well as the state can use to track and trend, and identify emerging issues
about potential food safety as well as evaluate future sampling initiatives and areas of focus. The
funding from this new cooperative agreement can help equip the Agricultural Chemistry
Laboratory with additional resources to build and increase sample throughput capacity and
capability for our state to respond to any safety hazards requiring multi-state response and
national coordination/ support.

Public health relevance
Project Narrative Funding under this cooperative agreement will enhance the capacity and capability of the Agricultural Chemistry Laboratory to test animal food products for both microbiological and chemical contaminants to support the national integrated food safety system established by the FDA. This increased surveillance can help the agency identify food safety issues and develop strategies to either prevent or respond to foodborne illnesses.